Characterization and disruption of bacterial microcompartment shells from human pathogens

Project Summary/Abstract: Many pathogenic bacteria utilize protein-based nanoreactors called bacterial
microcompartments to metabolize diverse nutritional sources. This helps pathogenic organisms thrive in
human tissues. The bacterial microcompartment is a specialized organelle composed of enzymes surrounded
by a protein shell. To function, compounds to be broken down within the bacterial microcompartment must
cross the shell and, likewise, the breakdown products must egress the compartments. The goal of the
proposed research is to study and disrupt the protein-protein interactions essential for shell integrity. In parallel,
we will characterize the permeability properties of BMC shells, and screen for compounds that interfere with
flux across the shells. Collectively these data will provide new knowledge about the structural basis of shell
function and provide the foundation for producing therapeutics that disrupt shell assembly and permeability.

Public health relevance
Project Narrative: Many pathogenic bacteria contain specialized nanoreactors that selectively enable them to derive energy while infecting human tissues. The proposed research aims to understand the structure of these nanoreactors, and how they communicate metabolically with their environment and use this information to disrupt nanoreactor assembly and function. The results of this study will be useful for design of therapeutics that can selectively disrupt formation and function of these nanoreactors in pathogens.